PHASE IIA STUDY OF DMP 777 IN ADULT PATIENTS WITH CYSTIC FIBROSIS

The objectives of this study are to evaluate safety and tolerability of multiple oral doses of DMP 777 in three different dose levels; to determine pharmacokinetic and pharmacodynamic characteristics of multiple oral doses of DMP 777 at three different dose levels; and to define DMP 777 dosage level necessary to achieve sustained high-level systemic neutrophil elastase inhibition as determined by measurements of circulating PMN-lysate AAPVase inhibition and whole blood urea fragment levels in a selectively defined cohort of patients with cystic fibrosis following twice daily (every twelve hours) oral administration of DMP 777 for nine days duration. This is a multicenter, randomized, double-blind, placebo-controlled, dose-escalation design. Patients will be entered in one of three DMP 777 dosing groups across three sequential cohorts. Patients will be required to remain confined in a clinical research unit or similar facility for two periods, each a minimum of 24 hours, on Day 1 and Day 7.